A pulse-driven micropump for continuous drug delivery

A pulse-driven micropump for transdermal drug delivery
PROJECT SUMMARY/ABSTRACT
Ambulatory infusion pumps are an increasingly prescribed therapy modality for cancer and diabetes patients,
post-operative pain management, and more. They allow patients to receive necessary medication infusions,
but are often bulky, tethered to the user with tubing, and associated with pain at the insertion site. These
shortcomings make drug regimen adherence harder for infusion pump users, particularly those with chronic
conditions. To eliminate barriers to infusion therapy adherence, there is a critical need for compact, lightweight
infusion devices that don’t impede physical activity. Our long-term goal is to improve infusion therapy
adherence by developing featherweight arterial pulse-driven infusion pump technology that eliminates the need
for painful cannula insertions and motors and batteries to facilitate pumping. Our overall objectives in this
project, the next steps toward our long-term goal, are to (i) characterize the infusion rate capabilities of a
prototype pulse-driven micropump based on our recent advances in bio-inspired microfluidic pump technology,
and (ii) tune the micropump design to deliver a set of target infusion rates within its range by way of physical
experiments, computational modeling, and AI-guided optimization. Our central hypothesis is that our pulse-
driven microfluidic pump technology, which mimics natural biological function, can provide drug delivery rates
appropriate for clinical applications like ambulatory chemotherapy for a wide range of users with varying
arterial pulse profiles. Our hypothesis is based on preliminary data demonstrating the proof-of-concept that our
prototype micropump can be powered by the human radial artery pulse and produce flow rates appropriate for
chemotherapy and insulin delivery. The project’s rationale is that, before the proposed pulse-driven micropump
can be developed for clinical use, its capabilities must be characterized, allowing its design to be optimized for
specific applications. To attain these objectives, the following specific aims will be pursued. First, we will
determine the dependence of the micropump flow rate on device design parameters and arterial pulse
characteristics using in vitro and in vivo tests with rapid prototype micropumps produced using microfluidic
fabrication techniques and 3D printing; next, we will develop a 3D finite element model (FEM) of the prototype
micropump; finally, we will use an evolutionary algorithm along with human subject and porcine skin
transdermal flow rate testing to develop an initial set of 6 wearable infusion patch pump designs integrated with
microneedle arrays. Upon project completion, we expect our contribution to be a featherweight pulse-driven
infusion pump capable of producing a wide range of infusion rates that can be integrated into low-cost,
disposable infusion devices the size of a nicotine patch, or in state-of-the-art closed-loop and implantable
infusions systems, greatly reducing the footprint of both types of devices. This advance in infusion technology
is expected to increase users’ adherence to their drug regimens, reduce risk of diabetic hyperglycemic crises,
and improve quality of life for many patients. The technology has an additional potential application in self-
administered vaccine patches.

Public health relevance
A pulse-driven micropump for transdermal drug delivery PROJECT NARRATIVE Ambulatory infusion pumps allow millions of patients to go about their daily lives while receiving potentially lifesaving infusions of parenteral nutrition, chemotherapy, postoperative pain medication, and IV antibiotics, but they are bulky, usually connected to the patient via tubing, conspicuous, and can involve pain at the access site, which are the primary self-reported reasons that insulin users, for example, don’t adhere to their insulin regimes. To address these challenges, we developed a featherweight, pulse-driven micropump a fraction of the size of current battery-and-motor driven infusion pumps. Widespread adoption of this minimal, biology-mimicking, pulse- driven pump technology in infusion devices would dramatically shrink their footprint, lowering barriers to ambulatory infusion therapy adherence and transforming the quality of life for patients needing infusions.